Modulation of Corneal Endothelial Mitochondrial Activity and Dysfunction by Estrogen

“Modulation of Corneal Endothelial Mitochondrial Activity and Dysfunction by Estrogen”
ABSTRACT
The broad long-term objective of this project is to determine if estrogen is protective or detrimental to the
health of corneal endothelial cells. Estrogen has been shown to be protective of many tissues and this protection
is lost during menopause. Estrogen has many cellular effects including modulation of mitochondrial activity and
antioxidant status. The corneal endothelium, responsible for maintaining the transparency of the cornea, is
metabolically very active and has a very high density of mitochondria. Fuchs Endothelial Corneal Dystrophy
(FECD) is characterized by an accelerated loss of endothelial cells, basement membrane deposits (guttae), and
corneal edema. FECD specimens show dysfunctional mitochondria, reduced mitochondrial density, and high
levels of oxidative damage to DNA, protein, and lipids. Two-thirds to three-quarters of FECD patients are
postmenopausal women, suggesting that like glaucoma, macular degeneration, dry eye, and cataract, estrogen
is protective. Conversely, an alternate hypothesis that premenopausal estrogen exposure is toxic to the
endothelium via UV-light facilitated formation of nuclear and mitochondrial Estrogen-DNA adducts has been put
forth. Studies examining estrogenic effects on corneal endothelium have been done with cultured cells or an
acute damage model in mice. FECD however develops slowly over many years. Therefore, mouse models that
provide a slower development of endothelial dysfunction will be best for determining if estrogen modulates
dysfunction. To test the hypothesis that estrogen influences endothelial function, mitochondrial activity, or
antioxidant capacity, in Specific Aim 1 corneal thickness, Endothelial Cell Density and morphology will be
measured in an equal number of male and female estrogen receptor knockouts (KO) over one year. At that time
endothelial explants will be examined for levels of mitochondrial activity and density; reactive oxygen species;
oxidative damage and gene expression changes. Using the same methods, in Specific Aim 2, to test if estrogen
protects the corneal endothelium, we ask if sex is a factor in oxidative stress models of endothelial dysfunction.
Lastly, in Specific Aim 3, using a relatively new mouse menopause approach, we ask if corneal endothelial
function is better, worse or the same in oxidative stress models following menopause. Together, completion of
the aims will determine unequivocally whether the corneal endothelium is protected by estrogen, damaged by
estrogen, or neutral. If protective, estrogen receptor agonists could delay progression of FECD and extend the
useful life of endothelial grafts. If estrogen receptor agonists are going to be used to treat dry eye disease, lower
IOP, or protect retinal ganglion cells in glaucoma or other eye disorders, it is essential to know if estrogen is
protective or toxic to the corneal endothelium.

Public health relevance
Three-quarters of patients with Fuchs Corneal Endothelial Dystrophy, a blinding eye disease, are postmenopausal women. The goal of this project is to determine if estrogen protects corneal endothelial cells. Completion will answer this basic question and could lead to new therapies for this eye disease.